Proj 2 - Exploiting Therapeutic Vulnerabilities

Neuroblastoma (NB) represents a prototypical pediatric cancer genetically, in that point mutations are rare, but amplifications and segmental chromosomal copy number alterations (CNAs) occur commonly. Notably, amplification of the MYCN oncogene and loss of chromosome 1p are both prominently associated with highrisk disease. While these events commonly co-occur, their interdependence is poorly understood. We hypothesize that both loss of chromosome 1p and amplification of MYCN create unique vulnerabilities to therapy, including immunotherapy. MYCN amplification can be accurately modeled in immune-intact genetically engineered mouse models (GEMM), but chromosome deletions have been challenging to model. Using normal human induced pluripotent stem cells (iPSC) and CRISPR/Cas9 technology, we generated isogenic in-vivo NB models driven by MYCN, observing increased penetrance in tumors carrying both MYCN and engineered deletions in chromosome 1p. We thus have modeled MYCN-driven NB in the presence or absence of 1p deletions, enabling us to identify therapeutic vulnerabilities associated with 1p loss. MYCN broadly impacts the tumor immune response through regulation of checkpoint proteins such as PD-L1. We have tested an array of targeted and conventional therapies for the treatment of NB, many directed against MYCN, but the effects of these on the immune system are poorly understood. With recent FDA approval of dinutuximab monoclonal antibody directed against the surface marker GD2, targeted immunotherapy is now standard-of-care for NB. Using a MYCN driven mouse model developed in the PI’s lab, we will characterize NB tumors with CyTOF mass cytometric single cell proteomics to measure markers of immune cells, tumor cells, and signaling in both tumor and host cells simultaneously to identify and characterize small molecule inhibitors that cooperate with immunotherapy in the treatment of neuroblastoma. A1: Utilize human stem-cell based in-vivo models of neuroblastoma to identify therapeutic vulnerabilities associated with chromosome 1p deletion A2: Leverage MYCN-driven immunocompetent models of NB to identify effective combination therapy, focusing on immunotherapy. Successful completion of Aim 1 identifies therapeutic vulnerabilities in high-risk NB driven by both MYCN amplification and 1p deletion. Successful completion of Aim 2 identifies targeted therapies that cooperate with immunotherapy in the treatment of MYCN-driven NB. Both aims propose characterizing existing mouse models of NB to leverage opportunities in precision medicine (immunotherapy and 1p-directed therapies). This characterization provides targets, biomarkers, and actionable therapies for clinical trials in children with NB.

Public health relevance
We have modeled MYCN-driven neuroblastoma in human stem cells, in the presence or absence of 1p deletions, and are concurrently characterizing the immune microenvironment in mice transgenic for TH-MYCN, a mouse model developed in the PI’s lab. We hypothesize that both amplification of MYCN and loss of chromosome 1p create unique vulnerabilities to therapy, including immunotherapy. We propose to identify therapeutic vulnerabilities driven by 1p deletion, and to identify targeted therapies that cooperate with immunotherapy in the treatment of MYCN-driven neuroblastoma with the goal of improving survival and decreasing morbidity for children with this deadly disease. This proposal also addresses at least three of the NIH’s “provocative questions” in pediatric oncology including what vulnerabilities can be identified through CRISPR screens, what are the effects of losses of large segments of the chromosome, and how can mouse models define the effects of therapy on normal tissues.